Role of a Novel Hormone Complex, Fabkin, in Dyslipidemia and Inflammation in Atherosclerosis

Project Summary:
Despite effective strategies for lowering cholesterol, atherosclerosis, and related cardiovascular diseases remain
the leading cause of death worldwide, even in the COVID era. Recent clinical data highlights a key benefit of
targeting inflammatory processes in atherosclerosis. Thus, the discovery of novel therapeutics that can modulate
both dyslipidemia and inflammation would represent a major breakthrough for atherosclerosis treatment. This
proposal is focused on the fatty acid-binding protein 4 (FABP4) hormone complex we discovered, called Fabkin,
as a key mediator of dyslipidemia and inflammation that contributes to atherosclerosis. In Fabkin, FABP4,
adenosine kinase, and nucleoside diphosphate kinase interact to regulate extracellular ATP and ADP levels,
which signal through purinergic receptors. Our long-term goal is to understand Fabkin's roles and mechanisms
in physiology and cardio-metabolic pathophysiology and elucidate translational opportunities. Our objective in
this proposal is to elucidate the roles and mechanisms of Fabkin in lipid metabolism and inflammation and
assess its potential as a therapeutic target for atherosclerosis. We hypothesize that Fabkin is a key regulator of
hepatic lipid metabolism and a pro-inflammatory factor, contributing to dyslipidemia and macrophage
inflammation via purinergic signaling to promote atherosclerosis. This is based on available evidence of a role
of purinergic signaling in atherosclerosis, our compelling preliminary data showing that mice lacking adipocyte
FABP4 hormone, or treated with Fabkin-targeting monoclonal antibody, are protected from dyslipidemia and
atherosclerosis, and our experiments supporting a role of Fabkin to induce de novo lipogenesis (DNL) and very
low-density lipoprotein (VLDL) secretion in hepatocytes, and inflammation in macrophages. We will test our
hypothesis in the following three specific aims: 1) Determine the effect of in vivo Fabkin deficiency on
dyslipidemia and atherosclerosis. 2) Elucidate the roles and signaling mechanisms of Fabkin in hepatocyte DNL
and VLDL secretion, 3) Identify the roles and signaling mechanisms of Fabkin in macrophage responses to
cholesterol stress. In Aim 1 we will treat ApoE-/- mice with Fabkin-targeting antibody and employ ApoE-/-Ndpk-/-
mice to examine the effects of in vivo Fabkin deficiency on atherosclerosis, dyslipidemia, and hepatic DNL and
VLDL secretion. In Aim 2 we will characterize Fabkin's direct effects on hepatocyte DNL and VLDL secretion in
vitro, test the efficacy of Fabkin-targeting antibody, and identify the purinergic signaling pathways induced by
Fabkin. In Aim 3 we will determine Fabkin's direct effects on macrophage responses to cholesterol stress in
vitro, including foam cell formation, inflammation, ER stress, and cell death. We will also test the efficacy of
Fabkin-targeting antibody and identify the underlying purinergic signaling pathways. The expected outcome of
these studies will be a clear understanding of the functions and mechanisms of action of Fabkin in lipid
metabolism and inflammation, and its potential as a novel therapeutic target for treating atherosclerosis.

Public health relevance
Project Narrative: The work proposed in these aims will determine the role of the newly discovered FABP4 hormone complex, Fabkin, in the regulation of lipid metabolism and inflammation, specifically investigating the pathological role of Fabkin in promoting hepatocyte-mediated dyslipidemia and macrophage inflammation in atherosclerosis, as well as the therapeutic potential of targeting Fabkin for the treatment of this disease. This work will provide novel insights into the molecular mechanisms connecting metabolism, inflammation, and disease pathogenesis in atherosclerosis. In the face of ongoing cardiac-related mortalities despite current treatments, the potential for the discovery of new therapeutic strategies or targets arising from this work is highly relevant to public health and to the NIH mission.